STIM: Stimulation Therapy to induce Mothers: a Multicenter Trial

ABSTRACT
Over 1 million women have their labor induced in the United States each year, and synthetic oxytocin infusion
is the most common method used. However, compared to spontaneous labor, medical induction is resource-
intensive, has increased obstetric risks, and is associated with less successful breastfeeding. In contrast to
endogenous oxytocin hormone which is released in a pulsatile fashion in the brain, synthetic oxytocin is
continuously infused intravenously, resulting in important limitations related to efficacy, safety, and cost.
Akin to spontaneous labor contractions, infant suckling of the breast nipple is known to stimulate the pulsatile
release of endogenous oxytocin from the posterior pituitary gland. Nipple stimulation therapy via electric
breast pump similarly stimulates endogenous oxytocin release, and our preliminary work shows that it is a
feasible and acceptable inpatient method that results in a desirable uterine contraction patter n in nulliparas.
Our pilot study of 100 randomized nulliparas showed that intrapartum nipple stimulation therapy decreases
labor duration and trends toward a significant increase in the rate of spontaneous vaginal delivery compared
to synthetic oxytocin infusion. Further, nipple stimulation reduced the dose and duration of synthetic oxytocin
even when adjunctive synthetic oxytocin was used. Therefore, nipple stimulation therapy will likely prove to
be an efficacious labor induction method that increases the likelihood of spontaneous vaginal delivery, and
also have added physiologic benefits. For example, nipple stimulation triggers lactation by inducing the milk
ejection reflex, and our preliminary work also shows that nipple stimulation therapy via electric breast pump
results in early colostrum production and milk letdown in the majority of women, including first-time mothers.
Earlier lactation would alleviate the most common reasons for early breastfeeding discontinuation by
improving maternal perception of insufficient milk supply and the severity of weight loss that occurs in infants
in the first few days of life as they establish feeding. This in turn would improve the likelihood of sustained
breastfeeding for the recommended 6 months, which also has many short- and long-term benefits.
Consequently, nipple stimulation therapy during labor has tremendous potential public health and cost
benefits, and its success would be particularly important in areas of poverty, including developing countries.
We propose a multicenter randomized trial at Yale and Northwestern Universities to compare inpatient
nipple stimulation therapy via electric breast pump versus immediate synthetic oxytocin infusion without
nipple stimulation for nulliparous women undergoing labor induction. This trial of 988 nulliparous women will
provide adequate statistical significance to detect clinically meaningful differences in delivery mode and
breastmilk as the sole source of nutrition for newborns. Successful completion of this proposal will provide
rigorous data to help us show how this novel and potentially cost-effective method can radically change the
way we induce labor and positively impact breastfeeding success and early infant nutrition through lactation.

Public health relevance
PROJECT NARRATIVE Synthetic oxytocin infusion, the current standard clinical method used to induce labor, has important shortcomings. Breast nipple stimulation triggers the pulsatile release of endogenous oxytocin hormone in the brain to induce spontaneous contractions, stimulates lactogenesis, and has other physiological benefits. Therefore, the current proposal seeks to examine whether inpatient nipple stimulation therapy via electric breast pump during labor induction results in a greater likelihood of spontaneous vaginal delivery, improves the frequency of exclusive and sustained lactation postpartum, and is more cost-effective than synthetic oxytocin infusion without nipple stimulation among nulliparas.